Administrative Core

Abstract: Administrative Core, University of California, Los Angeles
This Program Project involves the active participation of researchers from 4 different institutions, each of them
located in a distinct location (University of California, Los Angeles; Pasteur Institute; The Medical College of
Wisconsin, and Duke University). The effective integration and communication of the different participants in
this initiative is critical to achieve the aims. The primary goal of the Main Administrative Core (located at UCLA)
is to facilitate communication and integrate Projects and Cores and manage administrative aspects needed for
the smooth operation of the Program. Note that there is a separate International Clinical Administrative Core
located at Duke University that is responsible for administrative aspects of international coordination, including
data and sample management. The specific objectives of the Main Administrative Core are the following: 1) To
promote integration, rapid communication and effective collaboration between the members of Projects and
Cores; 2) To support exchange of information, reagents, methodologies, expertise and data among all members
of the Program Project; 3) To implement and maintain an External Scientific Advisory Board that will be tasked
to critically evaluate the progress of the Program; and 4) To manage all administrative and compliance functions
associated with the Program Project. Integration of project and core members will be accomplished by organizing
various types of meetings to increase interaction, exchange of information, re-prioritize strategy and
communicate results through publications and reports. Four types of meetings will be implemented: 1) annual
meetings of PIs and Co-PIs with the External Scientific Advisory Board; 2) quarterly meetings of all research
personnel associated with all projects and cores to present progress through video-conference; 3) monthly
meetings through videoconference of the management team to discuss status of the Program Project, resolve
potential problems and overview the budget; and 4) bimonthly project meetings to discuss ongoing activities,
problem solving, and planning. The integration of all program project personnel will be facilitated using the
Microsoft Teams calendar, meeting, chat, and project management tools. An important task of the Administrative
Core will be to make sure the Program Project is advancing in the accomplishment of the goals and timelines
originally proposed, but also to incorporate new ideas and methodologies that may arise. This will be achieved
with the help of the Scientific Advisory Board during the annual meeting where we will review and evaluate the
scientific progress and re-prioritize effort if needed.